Age differences in perceptual consequences of noise exposure

PROJECT SUMMARY:
Synaptopathy, loss of functional synapse between hair cells and their afferent neurons, is thought
to be of central importance in the development of auditory deficits such as speech perception and
sound discrimination in noisy environments. Noise exposure during the lifetime is thought to be
an important contributing factor to synaptopathy. Investigation of this problem is difficult in humans
in part due to the difficulty confirming loss of auditory synapses in living humans and the limited
knowledge of the effects of biological variables such as age on noise-induced synaptopathy.
Importantly, synaptopathy can experimentally investigated in animal models such as mice, which
have emerged as a leading research tool in auditory neuroscience. The overall objective of the
proposed experiments is to identify age-dependent effects of noise exposure in a mouse model
of noise-induced synaptopathy. The proposed studies will apply a battery of well-defined
psychoacoustic tests in a well-controlled mouse model of synaptopathy. The mouse model affords
us the opportunity to screen animals exposed as young or older adults to synaptopathy-inducing
noise on behavioral and electrophysiological measures to detect dysfunction in addition to
performing anatomical assays to confirm the pattern of auditory nerve synapse loss and central
reorganization. We will pursue our objective through three aims: 1) Measure the effects of noise
exposure on the perception of spectral, temporal, and intensity cues in young and old mice; 2)
Measure the effects of noise exposure on the perception of spectrotemporally complex stimuli; 3)
Measure central gain compensation and the underlying changes in synaptic reorganization in the
auditory brainstem. We will test for synaptopathy-related perceptual deficits in young and old mice
trained to detect or discriminate sounds in quiet and noise. Our preliminary data indicate that old-
exposed mice cannot recover as well as younger-exposed mice, and we hypothesize that this is
due to reduced central compensation in the older brain. Auditory nerve synapse numbers will be
quantified in all mice so that behavioral and physiological response patterns can be correlated
with patterns of peripheral synapse loss and central reorganization. The experiments outlined
here will reveal a suite of behavioral measures that can be used by clinicians to reveal
synaptopathy in human patients and will identify whether or not ABRs can be optimized to detect
synaptopathy.

Public health relevance
PROJECT NARRATIVE: The proposed experiments address the need to understand how age interacts with auditory nerve synapse loss, a condition referred to as synaptopathy, to produce behavioral hearing deficits. We will behaviorally characterize a number of aspects of hearing in quiet and noisy conditions in young and old mice exposed to noise, test auditory brainstem response abnormalities, and verify the pathology using anatomical techniques.